Characterizing the role of tumor suppressor phase separation and chromatin organization in maintaining genomic integrity

ABSTRACT
Cells must integrate competing DNA repair pathways and tightly control their chromatin landscapes to
maintain genomic integrity. Disruption of these control systems or defects in any one pathway result in a
mutational burden with profound physiological consequences to cells and tissues. DNA repair in human
cells is primarily performed by two mutually exclusive pathways governed by two different, well-
characterized tumor suppressors – non-homologous end joining (NHEJ) by 53BP1 and homologous
recombination (HR) by BRCA1. 53BP1 and BRCA1 are examples of intrinsically disordered proteins
(IDPs) containing large stretches of low complexity amino acid sequences. 53BP1 undergoes liquid-liquid
phase separation to form biomolecular condensates in vitro and at DNA lesions. Further, recent studies
hint that 53BP1 condensation also plays a major role in maintaining chromatin organization. Whether
BRCA1 has similar phase separation activity has not been established. In preliminary data, I show the
very first evidence that BRCA1 phase separates to form biomolecular in cells and in vitro.
Chromatin landscapes also play a vital role in maintaining genomic integrity. DNA damage response
requires dynamic rearrangements and specific chromatin modifications to elicit rapid recruitment of repair
factors. Conversely, repair factors and their complexes can also modify chromatin to drive repair
programs. Despite extensive study of 53BP1 and BRCA1 tumor suppressor activities and their repair
mechanisms, it remains unknown by what mechanism 53BP1 or BRCA1 condense and what role
condensations plays in DNA damage response. Further, the contributions of chromatin architecture to
repair pathway selection and chromatin organization within repair condensates have not been elucidated.
The goal of this work is to provide me with new training and expertise to address the proposed aims and
establish an independent research program. In Aim 1 (K99 phase), I will identify the specific sequence
determinants that promote 53BP1 and BRCA1 phase separation and determine the contribution of protein
condensates to promoting DNA repair and fidelity in repair pathway selectivity (NHEJ vs. HR). I will test
the hypothesis that the magnitude of tumor suppressor condensation contributes to pathway selection.
In Aim 2 (K99/R00 phase), I will define the dynamic rearrangement of chromatin in response to DNA
damage and how nucleosome clustering and DNA loop compaction contribute to chromatin dynamics in
53BP1- and BRCA1-mediated repair programs. Collectively, this work will address fundamental gaps in
knowledge regarding the role of phase separations in genome integrity and uncover new paradigms that
underlie tumor suppressor activities.

Public health relevance
Project Narrative Relevance to Public Health: This study investigates the fundamental mechanisms of self-assembly and liquid-liquid phase separation of tumor suppressors (53BP1 and BRCA1) and of chromatin organization in DNA damage responses. Mutations in 53BP1/BRCA1 or dysregulated chromatin architectures result in DNA damage accumulation and genome instability, which are strongly linked to cancer development as well as a myriad of other disorders of tissue physiology. Further, loss of 53BP1 function in BRCA1 mutant cells is associated with treatment resistance to PARP inhibitors, a major anti-cancer therapy.